Hyperoxia and enhancing efferocytosis in the eye

PROJECT ABSTRACT – Hyperoxia and enhancing efferocytosis in the eye
The remarkable advances in supplemental oxygen provision have been a huge benefit for preterm babies during a
critical phase of their development ex utero, but also have an unintended consequence of developing retinopathy of
prematurity (ROP). ROP is a leading cause of childhood blindness in the United States and worldwide, with a high
risk of vision loss or permanent impairment in severe refractory cases. During the disease course of ROP, many retinal
neuronal cells undergo cell death, which necessitates the clearance of the cell debris and corpses. The recognition
and removal of dying cells via the process of efferocytosis not only removes the debris but also promotes tissue
regeneration and healing (including angiogenesis). Interestingly, specific glial cells within the retina express
phagocytic receptors and other machinery that can promote efferocytosis. We have previously designed and validated
chimeric efferocytosis (CHEF) receptors, which improve the efferocytic capacity of phagocytes. Our recent preliminary
data in a mouse model of oxygen-induced retinopathy (OIR) suggest that CHEF receptor expressed in the microglia
can beneficially influence the OIR outcomes. This R21 application aims to investigate the interplay between
debris/dying cell clearance by specific phagocytes in the retina, and the possibility of improving retinal tissue healing
in OIR. Using recent knowledge on improving efferocytic clearance in vivo and transgenic mouse models developed
in our laboratory, we will ask two fundamental questions in this exploratory proposal. In Aim 1, we will address
whether cell-type specific expression of the CHEF receptor BELMO in Müller cells versus microglia will improve the
outcomes of OIR, coupled with mechanistic studies. In Aim 2, we will test a preclinical approach to express the CHEF
receptor TELMO (via mRNA based nanoparticle), coupled with studies using TELMO transgenic mice. Collectively,
we expect the studies via this R21 to provide exciting new insights and form the basis for exploring new avenues
targeting efferocytic pathways during ROP.

Public health relevance
PROJECT NARRATIVE The positive developments in the care of premature babies, via the provision of extra oxygen during a critical phase of their pre-term development, also have an unintended consequence of retinopathy of prematurity (ROP). This is a leading cause of childhood blindness in the United States and worldwide, with a high risk of developing severe refractory cases of vision loss. This proposal addresses the process of dying cell clearance in the retina and novel genetic approaches to enhance efferocytosis by glial cells of the retina for improved outcomes related to ROP.